San Diego IRACDA Scholars Program

ABSTRACT
A diverse U.S. biomedical research workforce is essential for developing innovation in basic, clinical,
translational research and healthcare and is necessary for improving the nation’s health. Despite decades of
efforts to increase underrepresented racial / ethnic groups and women in science their proportional
representation remains markedly low, especially in academia. The renewal application for the San Diego
IRACDA Scholars Program aims to enhance the successful transition of diverse biomedical scientists into
independent academic careers. San Diego “SD IRACDA” is a mentored postdoctoral career development
training program that provides training in rigorous and reproducible research, teaching training based on
scientific principles and professional skill development. SD IRACDA combines a mentored research-intensive
experience at the University of California, San Diego (UCSD) and mentored teaching training experience at
San Diego City College and San Diego State University (SDSU), two large undergraduate institutions that
serve diverse student populations. The overarching goal of SD IRACDA is to enhance the transition of diverse
biomedical scientists into independent academic careers, thereby increasing the diversity of academic faculty.
The specific objectives are to: 1) recruit and train a diverse pool of postdoctoral scholars that conduct rigorous
and reproducible research within the scope of the NIGMS-mission, 2) use evidence-based strategies to
enhance career skill development and effective mentorship of postdoctoral scholars, and 3) to provide teaching
training in scientific teaching principles and evidence-based practices. Other objectives are to enhance the
science curriculum at our partner-teaching intensive institutions, and to provide research opportunities for
partner institution faculty and students and role models and mentorship of students, thereby increasing the
number of diverse students participating in research and entering graduate programs in biomedical sciences.
Since its inception in 2003, SD IRACDA has trained 103 scholars, 62% are from underrepresented
backgrounds and 59% are women. Program evaluation has demonstrated that 63% of all SD IRACDA scholars
and 56% of underrepresented scholars have obtained independent faculty positions (94% tenure-track)
including a high percentage at R1 institutions, 32% of all scholars and 34% of underrepresented scholars,
respectively. Of SD IRACDA faculty alumni, 55% have received independent grant awards with the highest
percentage (31%) from the NIH. SD IRACDA scholars publish, obtain academic faculty positions and receive
post-fellowship funding at a greater rate compared to NIH F32-supported postdoctoral fellows at UCSD. SD
IRACDA has further benefitted the partner institutions, San Diego City College and San Diego State University,
by providing new and improved science curriculum, authentic research experiences and critical mentoring for
underrepresented students to enhance academic advancement and train the next generation of scientists.

Public health relevance
NARRATIVE The development of a highly skilled diverse workforce that will impact all aspects of health related research efforts is essential to sustain the Nation’s research priorities, scientific and economic competitiveness. The San Diego IRACDA Program will address this need by providing rigorous training in research, teaching and critical academic skills to a diverse group of postdoctoral scholars who will seek independent research and teaching careers in academia. The San Diego IRACDA Program will also enrich the science curriculum, improve teaching and learning at two large Hispanic-serving institutions in the San Diego area and provide critical mentoring and research experiences for underrepresented students that will enhance the training of the next generation of scientists.